NJ ACTS: A Platform for Translational Science in New Jersey

Abstract:
After 4 years, the New Jersey Alliance for Clinical and Translational Science (NJ ACTS), a partnership among
four institutions, Rutgers, Princeton Universities, the New Jersey Institute for Technology, and RWJBarnabas
Health, has profoundly altered the trajectory of clinical and translational science and research across NJ.
Designated as a Hub in 2018, NJ ACTS soon faced a devastating pandemic that served as a springboard to re-
imagine how we provided our services and facilitated research despite multiple logistic, staffing, recruitment, and
safety challenges. From these experiences, NJ ACTS can now reimage its programs and services to catalyze
breakthroughs in practices and policies that impact health. In the next 7 years, NJ ACTS will address and
overcome challenges and barriers that impede the progress of translation and the adoption of evidence-based
processes that will impact the health of NJ. Our approach to providing these solutions will be accelerated by our
strengths in dissemination and implementation (D&I) science, informatics, clinical trial performance, and our
ability to provide translational science services across the ecosystem. NJ ACTS seeks to advance CTS by
developing, demonstrating, and disseminating best-in-class processes, services, and training that incorporate
and advance team science, diversity and inclusion, D&I science, health policy, and the learning health system.
We will incorporate our diverse communities into our work, understanding their priorities and concerns. In this
way and especially through more representative participant populations, we will advance our understanding of
the heterogeneity of the disease and response to therapy and address health disparities. In Aim 1, NJ ACTS will
provide a sustainable infrastructure that will provide access to unique study cohorts, tools, and opportunities.
Aim 2 will use our strengths in community engagement to develop innovative interdisciplinary approaches to
improve population health. Aim 3 will enhance our workforce through targeted training, recognizing their
achievements through digital badging and certificates. In Aim 4, we will integrate large and disparate databases
with the EHR to provide reliable, comprehensive, and shareable data for interventional or observational clinical
trial research that in turn provides a roadmap to enhance healthcare delivery in diverse individuals, communities,
and populations. In partnership with the Consortium, we will propel CTS discovery, dissemination, and
implementation. Success will be defined using rigorous evaluation science approaches that will provide
directions for continuous improvement.

Public health relevance
Project Narrative: The New Jersey Alliance for Clinical and Translational Science (NJ ACTS), a partnership among four institutions, Rutgers, Princeton, the New Jersey Institute for Technology, and RWJBarnabas Health has profoundly altered the trajectory of clinical and translational science (CTS) across New Jersey. NJ ACTS now seeks to advance CTS further by developing, demonstrating, and disseminating best-in-class processes and providing infrastructure, services, and training that incorporate and advance team science, diversity and inclusion, health policy, and a learning health system. By moving discoveries to practice to policy, we hope to improve health, reduce inequities, and hope to understand why some, but not, all people acquire a disease or respond to therapy.